Graduate Training in Bioinformatics

ABSTRACT
Renewal is requested for a long-running and successful Environmental Health Bioinformatics (EHB) training
program at NC State University, with support for 5 predoctoral trainee slots, which will be augmented by generous
institutional support. This training program has produced scientists who occupy leadership and key scientific
roles conducting Environmental Health Sciences (EHS) research at academic, government, and industry
institutions. The structures supporting our EHB program, the Bioinformatics Research Center (BRC) and the
Bioinformatics Graduate Program, synergize with institutional strengths in training of predoctoral scientists. The
current proposal leverages the momentum in EHS and Data Science at NC State to further enhance EHB training
with (i) an expanded leadership structure, (ii) updated training elements and professional development activities,
and (iii) a revised training faculty. The administrative organization incorporates new ideas on best practices in
research training and enhancing diversity in recruitment, training, and professional opportunities. The revised
training faculty align with a new synthesis of EHB, where fundamental research in several disciplinary pillars
contributes to advancing EHS: Bioinformatics & Genomics, Quantitative & Computational Methods, and
Exposomics & Population Health.

Public health relevance
NARRATIVE The Environmental Health Bioinformatics (EHB) T32 training program leverages the unique confluence of strengths in Data Science and Environmental Health Science at NC State to train scientists fluent in this critical interdisciplinary space. This data-intensive training program will produce scientists ready to meet the emerging challenges in environmental health research, including the ever-expanding exposome, understanding of variability between individuals, rational integration across massive data sets, and study designs that incorporate diverse community goals and needs.